Flexible Funding Model - WV Manufactured Food Regulatory Program Maintenance

Project Summary:
The focus of the Flexible Funding Model – West Virginia Manufactured Food Regulatory
Program Maintenance project is to maintain conformance with the Manufactured Food
Regulatory Program Standards, support the West Virginia Food Safety and Defense
Task Force, and unify multijurisdictional response efforts to human and animal food
emergencies.
The West Virginia Manufactured Food Program will maintain and update procedures
and program quality assurance systems, implement staff training requirements, tailor
effective industry outreach, and improve sampling strategy and techniques. Additional
efforts to enhance the program include utilizing an electronic inspection system to
improve firm inventory maintenance, inspection report quality, and tracking of common
violations and violators.
The West Virginia Human and Animal Food Rapid Response Team will advance
response efforts by providing training to several agencies throughout the state, and
continuing work with district partners to refine multijurisdictional response.
The West Virginia Food Safety and Defense Task Force will meet one time per year.
The task force will provide a forum for all food safety and defense stakeholders,
including regulatory, industry, academia and consumers. Animal food representatives
will be included in the task force, and the focus of the task force will be regulatory
updates and targeting industry and public outreach.
The objectives of this project are to strengthen the WV Manufactured Food Regulatory
Program by effective regulation, appropriate and timely food incident response, and
bolstering relationships with food safety and defense stakeholders. The long-term goals
are continuous improvement of the West Virginia Manufactured Food Regulatory
Program, and to be part of an integrated food safety system.

Public health relevance
Project Narrative: The goals of the Flexible Funding Model – West Virginia Manufactured Food Regulatory Program Maintenance project are to strengthen the program by maintaining and enhancing conformance with Manufactured Food Regulatory Program Standards, continuing meetings of the West Virginia Food Safety and Defense Task Force, and improving response efforts to human and animal food incidents. The objective of the goals is to protect consumers by identifying issues early in the food safety system and implementing timely and appropriate control measures, resulting in the prevention of foodborne illness. In addition, maintaining conformance with program standards and fostering relationships with food safety and defense partners will advance efforts for West Virginia to become part of an integrated food safety system.